PHASE II AND III COMPARATIVE STUDY OF THERAPIES IN HIV 1 INFECTED CHILDREN

This is a Phase II/III comparative, multi-center trial of symptomatic HIV-1-infected children comparing the efficacy of lamivudine plus zidovudine vs. didanosine monotherapy vs. zidovudine plus didanosine. Results are determined by HIV disease progression based on time to development of first new CDC category C diagnoses, death, failure to achieve adequate weight growth velocity, or decline in neurological or neuropsychological assessments. This study was officially closed at Cincinnati in June 1997. The loss of NIH funding meant that our institution was in a close-out phase of the study for the first four months of 1997. No publications have as yet resulted from this trial. All patients who were previously enrolled in the ACTG trial at Cincinnati Children's Hospital were transferred to Columbus Children's Hospital, which remains a member of the ACTG.